Administrative, data management and biostatistics core

SUMMARY – CORE A
Core A, the Administrative Core, will serve all three Projects and three Cores over all five years of the Program.
The goals of the Core include: 1) To build an administrative and leadership Core that supports the cross-
disciplinary scientific and translational goals of our Program Project; 2) To broaden the Program Project
community of researchers; 3) To provide an environment that enables critical self-evaluation designed to
accelerate our scientific and translational aims.